DOBUTAMINE PHARMACOKINETICS AND CARDIOVASCULAR RESPONSES IN INFANTS AND CHILDREN

This study measures dobutamine metabolism and the specific newborn and pediatric heart rate and blood pressure responses to various doses of the drug.